Hit-to-lead optimization of broad spectrum antifungal phenothiazines

PROJECT SUMMARY
Fungal diseases affect an estimated 300 million people a year and lead to approximately 1.6 million deaths.
Despite the high prevalence of serious fungal diseases, no area of infectious disease drug development has
made less progress in the last fifty years than mycology. Of the three primary classes of drugs used to treat
invasive fungal infections (IFIs), amphotericin B was introduced in the 1950s; azoles were developed in the
1970s; and the echinocandins were approved in 2002. Unfortunately, this slow rate of progress is not because
these drugs are highly effective. Indeed, the mortality rates for invasive candidiasis, invasive aspergillosis, and
cryptococcal meningitis, three of the most common IFIs, remain unacceptably high at 30-40%, 50%, and
>50%, respectively. Furthermore, the poor outcomes associated with IFIs are likely to worsen as the incidence
of antifungal drug resistance continues to rise. Accordingly, the clear consensus in the field is that novel
classes of antifungal drugs represent one of the most pressing un-met clinical needs facing infectious disease.
One approach to expediting this development is to optimize the antifungal activity of drugs currently used to
treat other diseases. The phenothiazine class of molecules related to antipsychotic and antiemetic medications
has been shown by us and others to have antifungal properties. In preliminary studies toward optimizing these
compounds, we have been able to increase their antifungal activity and decrease their affinity for
neurotransmitter receptors, the prime driver of dose limiting side effects. Here, we propose a hit-to-lead
development of these phenothiazines focusing on structure guided reduction in dopamine/serotonin receptor
activity and reducing multi drug efflux affinity. Our goal is to advance 3-4 molecules into initial animal efficacy
studies. To achieve these goals we propose the following aims: 1) medicinal chemistry-based optimization of
the antifungal therapeutic index of the phenothiazine scaffold; 2) characterize the mechanism of increased anti-
candidal activity of novel fluphenazine and trifluoperazine derivatives; and 3) in vivo pharmacology and efficacy
testing of three lead candidates using murine infection models.

Public health relevance
PROJECT NARRATIVE Fungal infections affect an estimated 300 million people annually, causing considerable morbidity and mortality around the globe. While a wide range of evolutionarily divergent fungi cause infections that involve almost all human organs, we are forced to treat these patients with the most limited set of drugs in the anti-infective pharmacopeia. Specifically, only three classes of antifungal drugs can be used as primary therapies for life- threating fungal infections: polyenes; azoles; and echinocandins. Unfortunately, invasive fungal infections have mortality rates that are considerably higher than many other infections. The goal of this project is to develop a novel class of antifungal drug candidates for further pre-clinical development.